Cellular and Molecular Biology Training Program

The Cellular and Molecular Biology (CMB) Training Program has contributed to the success of over 1,700 graduate student trainees for nearly 50 years. The ongoing need for this program is driven by the essential role that research plays in advancing our understanding of fundamental biological processes affecting human health. By training the next generation of research scientists, these programs lay the groundwork for continued collective achievement in this critical area. The Cellular and Molecular Biology Training Program has several educational and research missions for our student trainees: (1) to train in the fundamental mechanisms that govern biological processes, specifically cellular and molecular biology, while developing a broad understanding of different biomedical disciplines; (2) to instruct in the use of ethical, rigorous, and safe methods in which to conduct research; (3) to cultivate reasoning skills so that students can independently address critical questions in cellular and molecular biology, using cutting-edge innovative approaches; (4) to foster a collaborative research environment that values the participation of individuals from different communities; (5) to build the ability to communicate scientific knowledge to a variety of audiences, including research professionals and non-expert individuals; (6) to advance the trajectory of our trainees after graduation through a variety of mechanisms that reveal the variety of career paths available; and lastly (6) to promote biomedical research as a societal responsibility and foundational tool to advance our understanding of human health.
Training students to be future leaders in biomedical research is crucial for advancing scientific knowledge, driving innovation, and developing a skilled workforce to improve overall human health and well-being. In order to accomplish our mission, we have developed a comprehensive training plan to provide: instruction in lab safety, research ethics, and rigor; foundational education in cellular and molecular biology; teaching experience; continuous development of scientific skills; a graduate community that inspires innovation; experience in science communication; and expansive career development opportunities. Stanford University and the CMB Program are exceptionally equipped to foster the talents of uniquely capable students. Within this extraordinarily collaborative environment, the CMB Program is a major force that unites a large community of cellular and molecular biology researchers by directly promoting intellectual and social interactions among faculty mentors and trainees across campus.
As described in this proposal, we appoint students in their 2nd and 3rd years of graduate training. The overwhelming majority of students successfully obtain a PhD in less than 6 years and transition to biomedical research careers. We are requesting an increase of 5 trainees to support a total of 30 students, ensuring the continued success and mission of the CMB Training Program.

Public health relevance
Project Narrative The goal of the Cellular and Molecular Biology Training Program is to train graduate students to be future leaders in biomedical research. This goal is crucial for advancing scientific knowledge, driving innovation, and developing a skilled workforce to improve overall human health and well-being.